Defining the role of BARD1 in nucleosomal ubiquitylation

PROJECT SUMMARY
BARD1 (BRCA1-Associated RING Domain protein-1) is an essential partner of the breast and
ovarian cancer tumor-suppressor protein, BRCA1, and is included in a panel of genes used to
evaluate patients with suspected hereditary cancer predisposition, especially breast and ovarian
cancers. Despite this, little is known about the cellular role of BARD1. This project aims to
address this serious gap in knowledge by defining at a molecular level how BARD1 contributes
to DNA damage repair and to transcriptional repression. An ultimate goal is to enable
predictions regarding potential loss-of-function phenotypes for mutations identified in patients.
BRCA1 and its obligate partner BARD1 form a heterodimeric complex that is implicated in
numerous cellular processes, most notably, transcriptional regulation and DNA repair via
homologous recombination. The sole enzymatic activity directly associated with the
BRCA1/BARD1 complex is as an E3 Ubiquitin ligase. The RING domains of BRCA1 and
BARD1 specifically and uniquely target positions on the tail of nucleosomal histone H2A. The
ability of BRCA1/BARD1 to place these Ub marks is essential to both its transcriptional
repression of certain genes and its function in DNA damage repair by homologous
recombination. While the RING of BRCA1 is required for all ligase activity, breast cancer patient
mutations in the RING of BARD1 display loss-of-function specifically for ubiquitylation of H2A. A
newly determined cryo-EM structure of the BRCA1/BARD1 RING domains sitting atop a
nucleosome reveals that BARD1 dictates the orientation of the E3 ligase and, therefore,
determines the site(s) of modification on H2A. In this project, we will build on this exciting new
structural insight to address how regions outside BARD1’s RING contribute to its function as an
essential partner of BRCA1.

Public health relevance
PROJECT NARRATIVE BARD1 (BRCA1-Associated RING Domain protein-1) is an essential partner of the breast cancer susceptibility protein BRCA1 and is included in clinical panels of genes used to evaluate patients with suspected hereditary cancer predisposition, especially breast and ovarian cancers. Despite this, almost nothing is known about the cellular role of BARD1. This project aims to address this serious gap in knowledge by defining at a molecular level how BARD1 contributes to DNA damage repair and transcriptional repression.